The Chicago Longitudinal Study: A low-income minority cohort from Birth to adulthood

Project Summary
The proposed project will archive the data from the Chicago Longitudinal Study (CLS), a large-scale prospective
investigation funded by the National Institute of Child Health and Human Development (NICHD) since 1995. The CLS
study sample is a cohort of over 1,500 minority low-income children who grew up in inner-city Chicago. The cohort is at
high-risk due to the minority status and poverty. The proposed project will archive the CLS data from birth to age 30.
Data will be archived include five areas: (a) Context and CPC program participation, (b) Academic performance and
school experiences from K-12, (c) Family experiences, including child maltreatment and adverse childhood experience
(ACE), (d) Criminology, including delinquency and adult crime, and (e) Well-being indicators between ages 19 and 30.
Archived data will allow researchers to investigate topics on developmental process of a cohort of disadvantaged children.
The negative effects of poverty on children’s early development and long-term outcomes are well documented. The
CLS data can be used to identify alterable factors that can be intervened early to improve success in adolescence and
adulthood. Recent findings from large-scale state preschool programs found positive effects of preschool at kindergarten
entry, but the effects fade out soon after. The fade out of the positive effects has been discussed since the 1990s and
remains a critical topic nowadays. The CLS data will allow researchers to replicate or conduct new studies on the effects
of CPC. The effects of ACEs on child development are substantial and long-lasting. However, ACE studies on minority
populations are rare. Researchers can use the CLS data to investigate the connection between ACE and child
development. Antisocial behavior originates as early as childhood. CLS data provide a unique opportunity to understand
the life-course criminology of a high-risk minority group starting from childhood, which will help to develop preventive
programs. Lastly, the longitudinal nature and richness of the CLS data allow researchers to apply sophisticated statistical
models or explore new methodological issues. Given the features of the study sample, data in the CLS is suited for
examining the developmental process of at-risk children and addressing important issues on at-risk children.
The design of the CLS is innovative because the data collection went above and beyond the intended factors and
outcomes associated with the CPC program planed in the original funded projects. In addition to collect data from
participants, teachers, parents, and schools, existing datasets, such as criminal records, postsecondary education, and
employment, were matched and linked to the CLS data, which enhances the potential scientific impact to a broad
community level, and goes beyond the intended educational outcomes to socio-behavioral outcomes and economic
wellbeing. The scale of data collection over 25 years is rare in social science. Moreover, the CLS constructed a significant
number of variables over the years based on multiple data sources and waves of available data. The data will be deposited
with the Data Sharing for Demographic Research (DSDR), housed within the Inter-university Consortium for Political
and Social Research (ICPSR) at the University of Michigan. DSDR will disseminate the archived data worldwide. Studies
using the archived dataset can have implications for policymakers and further the advancement of the research.

Public health relevance
Project Narrative The major contributions of the study are to archive and document the data from birth to age 30 from the Chicago Longitudinal Study the first time and provide researchers access to the dataset for new or replication studies on a high-risk sample of disadvantaged children. Archiving the CLS data will allow sharing of the unique research resources developed with NIH funds an important means to enhance the value and further the advancement of the research. Findings from future research can be translated to inform programs and policies for reducing disparities by race/ethnicity and socioeconomic status and improving the life chances of low-income children.